Platform for high-throughput biomechanical measurements using metallic islands on boron nitride nanosheets

SUMMARY This proposal describes a new platform for high-throughput measurement of mechanical phenomena in cells. The platform is based on a type of strain sensor comprising metallic nanoislands supported by hexagonal boron nitride. Mechanical deformation produces a change in both the electrical resistance and the optical scattering of these sensors. These processes allow the detection of deformations ?1 ppm (?0.0001% strain). This unprecedented level of sensitivity permits the measurement of minute forces produced by cells that cannot be measured using existing methods, and the electrical signals can be analyzed rapidly using machine-learning algorithms. While this sensor has a broad range of potential applications in cell biology, we apply it here to a ubiquitous challenge in cardiovascular medicine and drug discovery. In particular, contractile dysfunction in cardiomyocytes is associated with a range of difficult-to-treat cardiomyopathies. In drug discovery, cardiotoxicity (myopathy, arrhythmia, or both) is a leading reason for the failure of drugs during development and aftermarket launch. For some classes of drugs—especially those used in chemotherapy—up to 30% of patients experience heart disease related to their treatment. Indeed, heart failure is the second most common reason for death of cancer patients. There are currently no assays that are both predictive of cardiotoxicity and are of sufficient throughput to implement early in drug development (i.e., when safer drug leads can be selected among analogues). We propose the use of induced pluripotent stem cell-derived cardiomyocytes (iPSC-CMs) bearing various disease-associated mutations as a test case of our nano-enabled biomechanical sensor. In particular, we will construct an array based on a “96-well” plate format combined with high-throughput analysis using a purpose-designed machine learning algorithm in order to measure the forces and kinetics of contractility of the cells. Such a platform would enable large-scale evaluation of disease mechanisms and accelerate therapeutic target discovery by permitting high-throughput, unbiased testing. This application offers the exciting possibility of introducing aspects of the biology of the human heart early in the discovery pipeline. More broadly, the platform we describe offers the potential of answering deep questions about mechanical phenomena in cells??the mechanome??which play critical roles in human health.

Public health relevance
NARRATIVE This proposal describes a platform for high-throughput measurement of mechanical forces in cells, which play major roles in human health. The platform is based on a type of strain sensor comprising metallic nanoislands supported by hexagonal boron nitride. As an application of this platform, we propose to measure the forces stem- cell derived cardiomyocytes which bear genetically encoded contractile dysfunction for drug screening.